Cationic Carbone-Boracycles as Far-Red and Near-Infrared Photoactive Agents

Project Summary
Photoactive agent-based theranostics play an important role in the development of innovative
approaches for tumor diagnosis and treatment. Society stands to benefit greatly if methods to
detect and treat cancers at an early stage are enhanced, which often depend on our ability to
effectively visualize and send localized energy to specifics regions of the body. The central theme
of the proposed project involves the rational design, synthesis, and molecular and photophysical
characterization of cationic carbone-boracycles as far-red and near-infrared (NIR) photoactive
agents. The innovative approach involves utilizing carbone ligands as both σ- and π-donors,
which impart remarkable stability to cationic boron centers, ensuring the molecules remain stable
in biologically-relevant conditions and offering advantages for targeting and treating tumors.
Various boracycles are being targeted with unique ring fusions and sizes such that they have
appropriate electronic structures to make them suitable for potential applications in
phototheranostics. Specific aim #1 focuses on the synthesis and functionalization of cationic
boron heterocycles that emit in the near-infrared region, enhancing fluorescence/luminescence
imaging capabilities and facilitating photodynamic therapy (PDT). This includes the synthesis of
stable versions of conjugated cationic boron, nitrogen-acene derivatives and non-conjugated
anthanthrene bis-cations. Specific aim #2, which is independent of aim #1, focuses on the
development of non-emissive carbone-azulenes as biocompatible NIR absorbers. The hypothesis
is that the addition of the azulene unit will permit maximum absorption, such that all of the
absorbed light energy will be transformed into heat for potential applications in photothermal
therapy (PTT). In aims #1 and #2 the synthesis will be guided by computational chemistry and
the photophysical data will be simulated to obtain detailed information regarding the electronic
transitions that result in the optical properties. Specific aim #3 involves sophisticated optical
measurements to compare the photophysical properties of the newly synthesized compounds,
especially those that have undergone nanoencapsulation. These measurements include including
absorption and emission, quantum yield measurements, and fluorescence lifetimes. The goal is
to screen for compounds with suitable energy properties for biological screening at the MIT Broad
Institute. This interdisciplinary approach, combining main-group chemistry, photophysics, and
photobiology, highlights the project's innovative nature and potential for groundbreaking
advancements in bioimaging and cancer therapy.

Public health relevance
Project Narra+ve This proposal covers the ra/onal design, synthesis, and characteriza/on of ca/onic carbone- boracycles. The materials will be obtained using a novel synthe/c approach that allows for the development of diverse libraries of far-red and near-infrared photoac/ve agents that are stable under biologically-relevant condi/ons for advancements in phototheranos/cs (e.g., bioimaging, photodynamic therapy).